A Mechanistic Test of Treatment Strategies to Foster Practice Quitting

PROJECT SUMMARY/ ABSTRACT
Tobacco use remains the single leading preventable cause of death and disability in the United States,
accounting for 480,000 deaths and $170 billion in medical costs each year. Although most cigarette smokers
eventually want to quit, the majority (80%) are not interested in quitting within the next month. Despite this,
smoking cessation treatment programs are traditionally predicated on smokers’ motivations to quit, with
treatments proceeding only among those willing to set a quit date. This stands in stark contrast to treatments
for other chronic diseases (e.g., hypertension)—health care providers do not assess whether or not patients
are ready to treat their high blood pressure, they simply identify the problem and initiate treatment. Tobacco
treatment programs are beginning to move toward a similar strategy through population health management
approaches; however, there is a dearth of treatment content applicable to smokers across a range of quit-
readiness, particularly for those unwilling to set a quit date. One novel potential treatment strategy is to foster
practice quitting (PQ), in which an individual attempts not to smoke for a few hours or days, without pressure or
expectation to permanently quit. Although a growing body of evidence has supported the role of practice
quitting in fostering permanent quit attempts and cessation, there is limited understanding of the mechanisms
of PQ-focused treatment. Furthermore, no studies to date have attempted to disentangle treatment effects
associated with behavioral vs. pharmacological intervention strategies to prompt practice quitting. The overall
goal of the current research is to characterize treatment mediators of PQ-focused counseling and nicotine
replacement therapy (NRT) sampling. We will use a 2x2 factorial study design to test the role of PQ counseling
vs. Motivational Interviewing (MI) counseling, and NRT sampling (four-week supply of nicotine lozenges and
patches) vs. none on incidence of quit attempts at 6-months post treatment. We hypothesize that PQ treatment
components will have an additive effect, such that PQ counseling + NRT sampling will produce the highest
incidence of quit attempts at 6 months post-treatment. Participants (N=780) will be recruited through a
nationwide online recruitment strategy and all study procedures will be completed remotely. We will
purposefully recruit smokers who are not planning to quit in the next 30 days, and will examine baseline quit
motivation (i.e., motivation to quit in the next 6 months) as a potential moderator of treatment effect. Results
will advance our understanding of the behavioral process of practice quitting and the mechanisms governing
PQA-focused treatment strategies. This mechanistic evidence will address a key gap in the smoking cessation
treatment development literature, with the potential to increase intervention reach and efficacy to reduce
tobacco-related morbidity and mortality.

Public health relevance
PROJECT NARRATIVE Although ‘practice quitting’ is an intuitive first step to engage smokers in the cessation process, there is limited understanding of the best treatment strategies to foster practice quitting. The proposed research will test how practice quitting counseling and nicotine replacement therapy sampling impact potential mediators and smoking cessation attempts. The long-term goal of this line of research is to add to the smoking cessation treatment literature, particularly for smokers not yet ready to quit.